CTSA K12 Program at University of Minnesota

ABSTRACT
The University of Minnesota (UMN) CTSI is ideally positioned to implement and train multidisciplinary teams of
translational researchers from the 6 health science schools and colleges (Medicine, Public Health, Nursing,
Pharmacy, Dentistry, Veterinary Medicine), the broader University, and 2 major Twin City Hub Partners: the
Minneapolis VA Medical Center and Hennepin Healthcare. The UMN CTSI K12 Program will train highly
promising and diverse research-oriented Assistant Professors in clinical and translational science (CTS) using
multidisciplinary mentoring teams to advance their individual research projects and CTS skill sets. K12
Scholars will be trained for 3 years, including 2 years with NCATS K12 funding and 1 year of UMN support,
with access to some career development activities and mentoring beyond 3 years. This grant will support 6
NCATS-funded Scholars at a time. The Program will 1) provide rigorous, competency-based training in the
design and conduct of high-quality clinical and translational research with both required and individualized
components (including Responsible Conduct of Research, Reproducibility and Rigor, and Human Subjects and
Animal Protections); 2) ensure K12 Scholars acquire skills and experience in team science and community
engagement; 3) promote scientific and career development, including training K12 Scholars to be excellent
mentors, communicators, and leaders and offering experiential learning opportunities; and 4) support each K12
Scholar’s development of a productive translational research program, resulting in successful K and R01 grant
applications and transition to independence. This program builds on the current KL2 program and our
innovations in leadership and communications training, such as using personality assessments and optional
coaching to aid Scholars’ personal development. Planned enhancements include required training in data
health science with development of a new foundational course; augmented evaluation of mentoring
effectiveness; increased interactions with community and stakeholders, including a Community Mentoring
Program; increased education in dissemination and implementation science; and using Scholar portfolios to
demonstrate acquisition of the characteristics of translational scientists. We will expand the diversity of our
Community of Scholars through holistic review of K12 applicants and close interactions and near-peer
mentoring with special programs (Pre-K Discovery Scholars and Medical School Early Research Career
Awards). We will also augment our Scholars’ interactions with programs that introduce college and precollege
students, mainly from disadvantaged and underrepresented communities, to the health sciences. With these
innovations and activities in place and with robust institutional support, we expect our K12 Scholars to become
highly talented leaders in their fields, contributing to multidisciplinary investigations, disseminating their
research and expertise through multiple channels, and mentoring new generations of CTS researchers.

Public health relevance
UMN K12 Program Project Narrative This K12 institutional career development program supports two years of mentored research and training in translational science for highly-promising early-stage faculty at the University of Minnesota and partner institutions. The K12 Scholars are trained to increase the long-term public health impact of their research and to become the next generation of leaders in translational science and research by also including training in communication skills, leadership, team science and wellbeing. The program seeks to train a cadre of outstanding research faculty representing diverse backgrounds, fields of expertise and types of science, drawing on the breadth and depth of faculty and expertise at the University of Minnesota.